Novel Extracorporeal Device 'Amytrapper' To Remove Beta Amyloid In Alzheimer'sDisease

Abstract
Alzheimer’s disease is the most common cause of dementia and fourth most common cause of death.
Amyloid-beta (Aβ) plays a crucial role in initiation and progression of Alzheimer’s disease (AD).
Removal of circulating Aβ would shift the equilibrium in Aβ levels between brain and blood towards
blood. This shift would deplete brain amyloid levels and improve memory. Three commercial monoclonal
antibodies Adecanumab (Biogen), Lacenumab (Eisai) and Donanemab (Eli Lilly) have been approved by
the FDA after showing cognitive improvement by reducing amyloid. Recombinant Technologies [RT] has
developed an extracorporeal apheresis device, namely, Amytrapper Catheter to sequester blood Aβ. The
device is built on our IP-protected active pharmacological ingredient [API], a tetrameric retro-inverso
(RI) peptide, named Amytrap peptide. The device is a medically viable catheter which is coated inside
with the API. Amytrap peptide prevents Aβ self-aggregation by binding to a specific motif on Aβ that
promotes its misfolding and self-aggregation. Amytrap peptide has been shown to bind both soluble and
insoluble forms of amyloid efficiently with little side effects. The API is superior in that it is a small
peptide, not an antibody and it does not trigger any immunological side effects.
Previous research through SBIR phases I and II met or exceeded the intended goals. We completed the
following quantitative milestones: 1) we obtained proof of concept for a prototype Amytrapper Catheter
device in vitro. It bound and retained biotinylated Aβ42 (spiked) in a concentration dependent manner
from circulating fluids including sera or plasma from mice, rat and humans, in vitro. 2) we have obtained
in vivo proof of concept for the device in AD model rats. Blood amyloid reduction coupled with
behavioral improvement was observed in these rats after catheter-apheresis. 3) we have obtained
preliminary proof of concept with the device to remove native amyloid from blood samples of a small
number of patients with AD. 4) Completed market research for the device by partnering with Bio Heath
Innovations (MD) with the help of an NIA-sponsored TABA program which produced encouraging
feedback from key opinion leaders including end users 5) We have raised outside funds through
partnership with Start Engine Capital LLC via Regulation CF and we plan to continue this effort. This
phase IIB proposal is a necessary and logical extension of our ongoing research and commercialization
efforts that will bring the device from bench to the patient. We plan to improvise and optimize the
Amytrapper catheter device. Reflecting on these goals, in this proposal, we plan: in aim 1. Scaled up
synthesis (GLP grade), optimization and characterization of API, in aim 2. Fine-tune and improvise
Amytrapper Catheter device utilizing amyloid-spiked human blood samples, in aim 3. Confirm preclinical
POC on the streamlined catheter device by testing Amytrapper Catheter on blood samples from AD
patients and in aim 4. Complete regulatory filing and FDA clearance for Amytrapper Catheter. We have
partnered with Connecticut Innovations Inc, a local biotech venture investment firm and SA Capital
Partners NY, to raise additional private funds. This phase 2B award is likely to attract a syndicate of
investors to help us succeed in our commercialization efforts. At the end of this study, we would have
completed an IDE (investigational new device exemption) with the FDA for an eventual first in human
[FIH] study. We present well defined goals with realistic milestones and deliverables that is supported by
established players and partners. We believe that removal of amyloid by this device in AD patients will
significantly improve their living conditions and complement existing therapeutic regimen.

Public health relevance
Alzheimer’s Disease (AD) is a common disease leading to dementia affecting millions of people worldwide. Amyloid has been implicated as one of the initiating factors in Alzheimer’s. Therefore, it is a target in the treatment of AD. Unfortunately, treatment options to date are limited or have limited effects. Recombinant Technologies (RT) owns a patent on an active pharmacological ingredient (API) with demonstrated proof of concept in a clinically relevant mouse model for AD. Incorporating the same API, RT has designed and developed an extra-corporeal device, namely, Amytrapper catheter to capture circulating amyloid. The device works similar to hemodialysis equipment that removes urea in patients with kidney failure. RT now plans to perform additional research and development to optimize and fine- tune the device, demonstrate proof of concept in blood samples from AD patients, obtain an investigative device exemption (IDE) classification from FDA and get ready for a first in human pilot study. The proposed innovative device may lead to achieving a novel treatment strategy that improves the lives of patients with AD.